Translational Imaging and Phenotyping Core

The proposed Translational Imaging and Phenotyping Core (TIPC) will enhance and accelerate the
research of Center investigators by providing equitable access to efficient, cost-effective, rigorous, state-of-
the-art technologies for musculoskeletal phenotyping that are generally not available in any single
investigator’s laboratory. Services are available for studies using animal models as well as clinical
investigations, and include histology & histomorphometry, microcomputed tomography, biomechanical
testing, quantitative MRI, high-resolution peripheral quantitative computed tomography, as well as
innovative analysis of genotype-phenotype associations using the Boston Children’s Hospital biobank and
image repository. The proposed core leadership brings together experienced investigators, Drs. Bouxsein,
Liu, and Kiapour, with complementary expertise. The proposed services are based on prior usage of the
Core, on input from Center investigators as well as from the recommendations of the the Innovation (New
Directions) Committee. Thus, the core will offer a mix of ‘tried and true’ services, in addition to cutting-edge
approaches designed to catalyze scientific advances by Center investigators, increase the impact of their
investigations and foster collaborations. Each service provided by the Core will be rigorously controlled for
quality performance and reliability. The Core will also lead efforts in education and training, by conducting
hands-on workshops in which investigators can be mentored and taught how to perform analyses on their
own. The Core will also conduct a seminar series to introduce new methodologies, approaches, and related
scientific progress to Center investigators.